Leveraging cell-instructive hydrogels to understand microenvironmental impact on wound healing processes

Abstract:
Wound healing after injury is accomplished by the coordinated action of several cell types that migrate to the
injury region and participate in tissue repair. Interactions between invading cells and the surrounding microen-
vironment are critical for the healing outcome. Current in vitro studies focus on comparing cell behavior in con-
ditions mimicking healthy tissue or fully fibrosed scar and mostly ignore the complex and dynamic properties of
the provisional matrix that plays a critical role in instructing cell processes during wound healing. The goal of
my research program is to develop cell-instructive biomaterials to support endogenous tissue repair after criti-
cal injury. My lab is at the forefront of designing injectable and microporous granular hydrogels with tunable
properties to support endogenous cell infiltration and tissue repair. While this approach presents intriguing pos-
sibilities for clinical translation, progress is severely hindered by a lack of knowledge on how endogenous cells
process the complex biophysical and biochemical properties of the provisional wound matrix and the implanted
hydrogels. A major aspect of our lab’s approach is the creation of in vitro platforms to model cellular interac-
tions, which serve the dual purpose of improving fundamental understanding of cell behavior in wound-mimick-
ing environments and rationalizing biomaterials design to elicit specific cellular behaviors. Over the next five
years, our lab will develop or advance in vitro models of endothelial sprouting, mesenchymal stromal cell para-
crine signaling, and fibroblast-driven matrix deposition, using synthetically designed modular hydrogels with
tunable porosity, ligand density, mechanics, and degradability. These hydrogel platforms will enable us to ad-
dress questions not easily answerable with traditional 2D coatings on plastic substrates or naturally derived
materials such as Matrigel that cannot be modified to recapitulate wound properties. Outcomes of projects in
these thematic areas will ultimately serve our overarching goal of leveraging the fundamental understanding of
cellular processes to design therapeutic biomaterials for effective wound healing in diverse tissue and organ
systems. Projects across all three themes have the potential to present several intriguing questions that can be
addressed with new hypotheses, experimental designs, and increasingly sophisticated biomaterial platforms
over the course of this funding period and beyond, making this proposal a perfect fit for the Maximizing Investi-
gators Research Award mechanism.

Public health relevance
Narrative The natural wound microenvironment and the biomaterials implanted to support its healing present complex biophysical and biochemical properties that must be navigated by invading endothelial cells, fibroblasts, and mesenchymal stromal cells during tissue repair. Hydrogels with tailorable properties like the one we propose to use allow the controlled culture of relevant cells in biomimetic environments allowing fundamental insights into cell behavior and their sensitivity to microenvironmental features. Our proposed projects will advance the basic understanding of endothelial cell invasion leading to angiogenesis, fibroblast activation leading to fibrotic scarring, and stromal cell paracrine signaling in wound-mimicking environments, ultimately enabling the discovery of broadly applicable tissue regenerative therapies.